2018 Neurobiology of Cognition Gordon Research Conference and Gordon Research Seminar

SUMMARY This proposal requests partial support for the fifth Gordon Research Conference (GRC) on the Neurobiology of Cognition, and for its associated Gordon Research Seminar (GRS) for trainees. The driving force behind the GRC is the rapid pace of convergent findings in molecular, cellular circuit and systems Neuroscience, augmented by technical developments in cell-targeting, imaging, computing and brain-machine interfaces. As a result, there are rapidly evolving descriptions of neuronal circuits and dynamics, neurophysiological processes and computational principles that underpin cognitive functions. The overarching goal of this GRC is to promote communication and collaboration across relevant levels of analysis and among empirical scientists, theoreticians and technical development specialists, emphasizing the most recent findings. The associated GRS, held just prior to the GRC, is designed to provide opportunities for doctoral and post-doctoral trainees to communicate their most recent findings and perspectives, and to prepare them for more in-depth participation in the parent GRC that immediately follows. Along with recent findings in traditional “core” areas such as memory and decision making, formal sessions will explore several new themes, including: 1) the evolutionary processes that have led to the human brain's cognitive abilities and 2) machine learning and its implications for cognitive neuroscience, 3) cognition in natural contexts 4) processing of sound for language, and 5) the brain as a network of interconnected areas. The program is highly interdisciplinary, bringing together behavioral, neuroimaging and electrophysiological techniques in humans and non-human animals with computational approaches that explicate empirical findings and construct realistic models to represent the developing picture of cognitive operations and guide future experimentation. The program also underscores novel, state-of-the-art experimental and theoretical approaches that promise to define fundamental principles of cognition, and to extend these to improved treatment of brain dysfunction. The format of the meeting promotes intensive interactions among investigators and trainees from different perspectives and analytic levels, and in particular, between experimentalists and theorists.

Public health relevance
PROJECT NARRATIVE The goal of this conference is to promote communication and collaboration among empirical scientists and theoreticians working in the field of cognitive neuroscience with the focus on the improved understanding of the biological basis of language, perception, memory, social cognition and decision-making. Insights into the neural basis of these fundamental cognitive processes, will lead to improved diagnoses and treatment of many cognitive disorders with profound implications for society, such as Alzheimer's and Parkinson's disease, schizophrenia and autism.